Mechanics of Cells & Tissues impact Chromosome Instability & Phagocytic Interactions

Project Summary – Project 2
Mechanics of Cells & Tissues impact Chromosome Instability & Phagocytic Interactions
Tumors evolve genetically via selection from a diverse population of cells with high levels of genetic variation. A
common cause is chromosome instability (CIN) due to impaired mitotic segregation. Paradoxically, mitotic errors
do not typically associate with mutations in genes involved in the core processes of mitosis. Our overall
hypothesis is that extrinsic mechanical factors – particularly 3D tissue/tumor architecture and its rigidity –
contribute to CIN and to the immune-sculpted evolution of aneuploidy. Conventional 2D cultures of cancer cells
are limited in elucidating roles for most tumor suppressor genes and oncogenes. Our in vitro and in vivo studies
will therefore collaboratively extend to 3D some of the key DNA damage/mitotic and immune signaling studies
of project 1 (Greenberg) as well as the myeloid-centric effects on tumors of project 3 (Shin/Haldar). Central
components of our studies also make use of two unique cores (Black, Chenoweth).
Disrupted tissue architecture, which is common in epithelial cancers, and loss of adhesion lead to mitotic
errors, but how these extracellular signals couple to internal mitotic processes is unclear. We propose that the
external and internal mechanics are linked as tension propagates from extracellular matrices to the cortex to the
mitotic spindle and ultimately to kinetochores. We will test the hypothesis that adhesion tightens the mechanical
coupling by manipulating either extracellular or kinetochore-microtubule tension, using mammalian artificial
chromosomes (MACs, with Black) and chemical optogenetic tools (with Chenoweth). We will also test whether
loss of tissue architecture and integrin function creates a vulnerability as cells are more dependent on other
pathways for maintaining tension, such as cortical rounding or microtubule crosslinking within the spindle.
Genome instability outputs including cytoplasmic RNA accumulation will be primary measures, extending to
signaling pathways (with Greenberg) via innate immunity.
Solid tumors are filled with macrophages that respond to numerous signals from nearby tumor cells, but
coupled effects of the confining and constricting rigidity of solid tumors are unknown. We will modulate and
visualize phagocytic interactions via ‘macrophage checkpoint’ disruption (CD47 on the cancer cell; SIRPa on the
macrophage) to test the hypothesis that this basic macrophage interaction (already in clinical trials) modulates
and is modulated by cancer genome variation. Single cell analyses will assess immune subtypes and signaling
interactions, which we will perturb (with Shin/Haldar). We will study the processes primarily in
immunocompetent, syngeneic B16 mouse melanoma model but also in an ovarian cancer model (with
Greenberg). We seek to determine whether 3D tumor tissue rigidity increases a tumor’s genetic variation,
particularly via CIN-initiated signaling, such as by micronuclei (with Greenberg). We will also determine coupled
effects of macrophage checkpoint disruption (including antagonist peptides from Chenowith), based on
preliminary data that already demonstrates durable cures with production of anti-tumor IgG.

Public health relevance
Project Narrative – Project 2 Solid tumors evolve genetically, which for therapy makes them a diverse and moving target, and we hypothesize that extrinsic mechanical factors – particularly 3D tissue/tumor architecture and its rigidity – contribute in key ways to chromosome instability and to the immune-sculpted evolution of aneuploidy. Several new and diverse molecular tools will be used in solid tumor type microenvironments (rather than 2D) to clarify mechanisms by which adhesion pathways affect mitotic fidelity including DNA damage processes that extend to signaling pathways and innate immune responses. Pan-cancer patient data further indicates that high levels of aneuploidy skews macrophages and somehow impedes Tcell checkpoint blockade (in melanoma), but with new approaches and tools we have focused on macrophage checkpoint disruption that preliminary data shows (in challenging B16 melanoma models) can produce durable cures, which now requires understanding the contributions of aneuploidy and microenvironment.